Mechanisms of replication fork degradation in vertebrates

PROJECT SUMMARY
DNA replication is constantly challenged by a variety of genotoxins that arise from the environment. These
genotoxins can be directly produced by the environment (e.g. UV and ionizing radiation) or can arise indirectly
in response to environmental agents (e.g. polycyclic aromatic hydrocarbons, reactive oxygen species).
Nascent strand degradation (NSD) and fork reversal promote genome stability in response to genotoxins by
facilitating replication fork restart. Despite the importance of nascent strand degradation and fork reversal,
there are many open questions about this pathway. For example, too much or too little degradation results in
genome stability. It is therefore important to understand how nascent strand degradation is efficiently triggered
when needed but with enough specificity that spurious degradation is avoided. However, we do not currently
understand how nascent strand degradation is triggered. Additionally, current models for nascent strand
degradation are too limited to explain the dozens of proteins currently implicated. Inherited defects in several of
these proteins are directly implicated in human diseases (e.g. SMARCAL1, BRCA1, BRCA2) suggesting that
defects in this pathway may alter individuals’ susceptibility to environmental genotoxins. Thus, it is crucial to
develop a robust paradigm for nascent strand degradation and fork reversal to establish exactly how this
pathway leads to replication restart and genome stability. Current approaches to study nascent strand
degradation and fork reversal lack the specificity and sensitivity to address these questions. To overcome
these limitations, we have developed a new site-specific, highly sensitive, and synchronous approach to study
nascent strand degradation and fork reversal in vitro using Xenopus egg extracts. This system contains the full
set of cellular proteins involved in DNA replication and DNA repair and provides unparalleled opportunities to
observe and manipulate these processes. Our new approach has already revealed key insights into the
requirements for nascent strand degradation and the mechanism by which it takes place. The proposed work
will combine biochemical and single molecule approaches, both in Xenopus egg extracts and human cells. We
will leverage our existing insights and exploit the power of our new system to determine how nascent strand
degradation and fork reversal are triggered and the underlying molecular mechanisms involved in these
processes. This work will enhance our understanding of one of the major cellular pathways that responds to
environmentally sourced genotoxins and allow us to better understand how defects in this pathway may alter
individuals’ susceptibility to environmental genotoxins.

Public health relevance
PROJECT NARRATIVE Environmental causes of cancer include chemicals and radiation, as well metabolites that are produced in response to environmental chemicals. These agents induce DNA damage that can be particularly detrimental during DNA replication and requires unique DNA repair processes to overcome. This project will investigate activation and functioning of these specialized DNA repair processes to understand how they mitigate environmental sources of DNA damage.